Maximizing GlyTR pan-cancer immunotherapy by enhancing target density

Abstract
Bi-specific antibodies and chimeric antigen receptor T-cells are the most potent cancer immunotherapeutics in
clinical use, yet most cancers remain poorly targetable. High-affinity antibodies required to maximize killing
detect low antigen expression in normal tissue, risking ‘on-target, off-cancer’ toxicity. This compels identification
of cancer-restricted cell surface protein antigens, which are rare. Tumor Associated Carbohydrate Antigens
(TACAs) are the most abundant and widespread cancer antigens known, but are poorly targetable by antibodies.
With funding from the Cancer Moonshot program, we developed Glycan-dependent T cell Recruiter
(GlyTR) pan-cancer immunotherapeutics that utilize high-avidity ‘velcro-like’ lectin binding to kill cells
with high but not low TACA-expression. GlyTR1 and GlyTR2 bind β1,6GlcNAc-branched N-glycans or
multiple TACA’s (Tn, sialyl-Tn , LacDiNAc, GD2), respectively, and trigger target-density dependent T cell
mediated pan-cancer killing with EC50’s as low as 10 femtomolar and effector: tumor (E:T) ratio = 1:140; yet lack
toxicity in mice with human-like TACA expression. The GlyTR1 bi-specific protein is undergoing IND enabling
studies at the NCI Experimental Therapeutics program for a Phase 1 basket trial in refractory solid cancer, and
similar translation of the GlyTR2 CAR T cell is pending. However, GlyTR target density can vary between cancers
from different individuals, limiting the number of patients that could maximally benefit from GlyTR therapy.
Moreover, targeting a single GlyTR antigen risks tumor escape. Therefore, here we propose to maximize
GlyTR target density/killing, increase the proportion of patients highly responsive to GlyTR therapy and
reduce risk of tumor escape using two different approaches: 1) engaging more targets by combining
GlyTR1 and GlyTR2 therapy and 2) metabolically increasing target density in cancer cells but not normal
cells. As GlyTR therapeutics are in late-stage pre-clinical development for planned Phase 1 clinical trials,
positive results from this proposal can be quickly translated into additional clinical studies.

Public health relevance
Project Narrative Directing the immune system to kill cancer cells is a highly potent way of treating cancer. Abnormal addition of carbohydrates to proteins is a near universal feature of cancer, however current immunotherapies cannot readily target these. Here we propose to maximize activity of a novel technology that directs immune cells to kill cancer cells based on expression of altered carbohydrates.